Catalytic Processes for Stereoselective Radical Cyclization Reactions

PROJECT SUMMARY/ABSTRACT
Catalytic Processes for Stereoselective Radical Cyclization Reactions
Cyclic structures, including both carbocycles and heterocycles, are common motifs of natural
products and synthetic compounds with important biomedical activities. Among different approaches for
preparing cyclic molecules, radical cyclization represents one of the most powerful approaches for
construction of ring structures. Among a number of inherent synthetic advantages, radical reactions
typically proceed at fast reaction rates under mild and neutral conditions in a broad spectrum of
solvents and exhibit significantly high functional group tolerance. Furthermore, radical processes have
the capability to perform in a cascade fashion, allowing for the rapid construction of complex molecular
structures with generation of multiple stereogenic centers. To further enhance the synthetic applications
of radical cyclization, new approaches will be needed for achieving high control of their reactivity as well
as stereoselectivity, especially enantioselectivity, challenging issues that are intrinsically associated
with the “free” nature of radical chemistry.
Guided by the mechanistic principles of metalloradical catalysis (MRC), this proposed research
explores a fundamentally different approach for controlling stereoselectivity of both C- and N-centered
radical reactions. Cobalt(II) porphyrins [Co(Por)], as stable 15e metalloradicals, can enable the
activation of diazo compounds and organic azides to cleanly generate C- and N-centered radicals,
respectively, with N2 as the only byproduct in a controlled and catalytic manner. The initially-formed C-
and N-centered radicals, which are termed as a-Co(III)-alkyl radicals and a-Co(III)-aminyl radicals,
respectively, remain covalently bonded with [Co(Por)]. They can undergo common radical reactions,
such as radical addition to alkenes and hydrogen-atom abstraction, but with effective control of
reactivity and stereoselectivity by the porphyrin ligand environment. In addition to the radical nature of
[Co(Por)], the low dissociation energy of Co–C and Co–N bonds plays a key role for the successful
turnover of the Co(II)-based catalytic processes, resulting in effective radical cyclization reactions.
Through the support of D2-symmetric chiral amidoporphyrin ligands with tunable electronic, steric, and
chiral environments, Co(II)-based metalloradical catalysis (Co(II)-MRC) will be applied for the
development of various radical cyclization processes for stereoselective construction of both carbocylic
and N-heterocyclic compounds with different ring sizes and varied degrees of molecular complexity.
We hope these studies will ultimately lead to the development of cost-effective and environmentally
benign radical cyclization processes that can be successfully applied for the stereoselective synthesis
of biologically important natural products and pharmaceutically interesting small molecules.

Public health relevance
PROJECT NARRATIVE Catalytic Processes for Stereoselective Radical Cyclization Reactions In modern pharmaceutical industry, where the market share of single enantiomer chiral drugs continues to rise, there are growing demands for developing practical and economical methods for the enantioselective synthesis of biologically and pharmaceutically important carbocyclic and heterocyclic compounds in an enantioenriched or enantiopure form. Compared to a racemic mixture, the use of an enantiomerically pure compound improves the desired bioactivity and while reducing toxicity because enantiomeric isomers often exhibit different biological activities. For drug discovery and development, it is desirable to prepare both enantiomers of a new chiral drug candidate for testing their separate activities.